Co-designing a Technology-based Health Research Results Dissemination Tool with AIAN People

PROJECT SUMMARY/ABSTRACT
This project aims to develop a culturally responsive technology tool for collaborative health research results
dissemination with diverse American Indian and Alaska Native (AIAN) communities. New methods and
technologies for respectful and culturally responsive research results dissemination are urgently needed both to
help researchers engage diverse participants and to serve those communities better. For many researchers, the
primary methods of disseminating research results are to submit manuscripts to peer-reviewed journals or
abstracts for conference presentations which essentially limits their audience to academic scholars. Limiting
dialogue between community stakeholders and researchers, many of whom may be unacquainted with
community perceptions of health or community systems of sharing information, decreases the likelihood that
study results will be implemented at a community level which can have a negative impact on community health
outcomes. Reliable health research information supports wellness but if that information is not presented using
methods that are understandable and contextualized, they have less benefit. AIAN people have experienced a
history of distrustful health research practice such as being exposed to procedures without informed consent
and having research results disseminated without community input or approval. Oversights like these increase
the need for transparency and accountability in research at all stages from project conceptualization to results
dissemination. Moreover, AIAN have been under-represented in large national health research initiatives—such
as NIH’s All of Us research program—or have not been consulted in meaningful ways about how best to
implement health research or disseminate actionable findings relevant to local community context. Though there
has been progress with community engagement in health research, only limited research has explored
collaboration specific to the results dissemination process. This study involves the co-design, co-development,
and evaluation of a stakeholder collaboration tool for health research results dissemination with AIAN
communities. For Aim 1, we will use value-sensitive design and user-centered design approaches to establish
value informed criteria to support activities for Aim 2A. In Aim 2A, we will integrate digital storytelling techniques
with participatory design methods to co-design low fidelity prototypes for collaborative results dissemination. Aim
2B will involve pilot implementation of a prototype designed with data obtained from Aim 2A which will be
evaluated for feasibility and acceptability in AIAN communities. Success in this research will result in improved
research communication and enhanced trust in health research which will increase the impact of health research
overall by ensuring that research outcomes are effectively disseminated to AIAN communities. This will support
the community in understanding and possibly incorporating research recommendations.

Public health relevance
PROJECT NARRATIVE This community-engaged study seeks to improve research results dissemination for American Indian and Alaska Native communities through co-designing collaborative technology systems. American Indian & Alaska Native people have experienced a history of distrustful health research such as being exposed to procedures without informed consent and having research results disseminated without community input or approval making community research collaboration critical from project conceptualization to results dissemination. Results from this study will inform future development of culturally responsive collaborative technology systems for health research results dissemination for use with marginalized communities.